The Health Sciences & Technology Academy – Alabama (HSTA-AL)

Project Summary/Abstract
This innovative project will replicate the successful Health Sciences & Technology Academy from West
Virginia, with important adaptations for our purposes, in rural Alabama (AL). This adaption will be called Health
Sciences & Technology Academy-Alabama (HSTA-AL). The long-term goal of this project is to build a more
diverse nursing, nurse faculty, nurse scientist and other biomedical professions workforce from among rural,
underserved, primarily African American, economically disadvantaged high school students in AL who will
become the first in their families to graduate from college. This goal will be accomplished by implementing the
HSTA-AL program to provide professional development to teachers designed to help teachers build science
content and pedagogical skills. Teachers will then guide students toward STEM fields by helping them learn to
conduct citizen science. These teachers can also transfer their learned skills for use in teaching other high
school students. To teach research skills to teachers and students, we will focus on conditions including
obesity and related cardiovascular conditions, risk behaviors, and opioid use that disproportionately affect
underserved AL communities. It is anticipated that through HSTA-AL activities, health literacy will be built
among the students and community members in these rural counties. The specific aims for this project are to 1.
Establish community led leadership teams comprised of 100% community members in each rural county
partner, and a joint leadership team for the state comprised of at least 51% community members to promote
community ownership of the HSTA-AL program. 2. Provide annual professional development for 5 teachers
and 5 preservice teachers per year across targeted communities for the purpose of promoting science and
research skills for HSTA-AL and other students to increase the pipeline of high school graduates from rural
areas into university STEM education, some of whom will choose nursing. 3. Provide summer camps annually
for 50 students to promote interest and skills needed for engagement in citizen science addressing issues
related to health disparities in rural AL and to promote exposure to the university environment, near-peer
mentors, STEM education, nurses, nursing education opportunities, advanced nursing degrees, nursing
science, and other biomedical professions. 4. Provide a club experience led by teachers for 95 high school
students across 5 years for the purpose of exposing students to STEM fields in general, nursing, and nursing
science by engaging students in community-based participatory research /citizen science addressing issues
related to health disparities in their communities. 5. Compare the outcomes of HSTA-AL to HSTA for
psychometric measures known to predict workforce development in biomedical fields to determine if replication
of the HSTA program in a rural, primarily African American, economically disadvantaged population is feasible
and effective. If HSTA-AL achieves similar outcomes to HSTA in West Virginia, we plan to expand this program
across AL and seek funding to support HSTA-AL students’ college and graduate school education.

Public health relevance
Project Narrative This proposal adapts West Virginia’s successful SEPA-funded Health Sciences & Technology Academy (HSTA) for the innovative purpose of building the pipeline of students to STEM health-related fields including nursing, nurse faculty, nurse scientists, and other biomedical fields from those underrepresented in the nursing workforce and from underserved rural communities in Alabama. HSTA-Alabama will provide professional development to teachers to build science content and pedagogical skills for use with HSTA-Alabama students and to use in their classrooms. Through a focus of addressing obesity in Alabama and its corresponding sequelae including cardiovascular diseases, other risk behaviors, and opioid use prevention, using a citizen science approach, we will mentor and facilitate professional preparedness of high school students from underserved communities for college and careers in STEM fields, and in particular into academic nursing and nursing science by empowering them to become agents of change in their own communities.